Biospecimen Repository Core

The NINDS Biospecimen Core Facility was established in February 2023 in a newly renovated laboratory space, Room 2N104, located in Building 10.

As of September 2024, the repository is actively storing, maintaining, and distributing samples from more than 15 different NINDS protocols. It is also collecting and processing clinical samples from 12 ongoing studies. Between February 2023 and the end of August 2024, the repository has accessioned and processed over 37,838 individual biological specimens for research use. The workload has steadily increased during this period, as awareness of the facility has grown and additional investigators have begun submitting samples. Several current investigators have also initiated new clinical protocols that involve the repository.

In support of its mission to preserve NINDS historical samples, the repository is currently sorting, accessioning, and transferring hundreds of specimens from Dr. Major’s collection. Additionally, preliminary discussions have taken place with Dr. Goldstein’s team regarding the transfer of a large collection of research samples from his laboratory.

The repository staff are also supporting various NINDS investigators by providing technical research services. One of the assays offered is the SIMOA (Single Molecule Array), which is considered a gold-standard method for measuring biomarkers of neurological injury and disease—such as Neurofilament Light (NF-L), TAU protein, cytokines, and other proteins. After receiving the necessary sample information and request, the Core can return assay data in a timely manner, offering researchers access to a specialized platform that might otherwise be difficult to implement in their own labs.

Another assay performed by repository personnel is the Seahorse assay for mitochondrial function. This technique uses clinical blood samples processed and assessed the same day. Over the past year, the Seahorse assay has been routinely conducted for all patients enrolled in the Long-COVID protocol, as well as for several other protocols and individual cases.

The repository also houses a Cytek spectral cytometer for multicolor flow cytometry. One of the Core’s scientists has extensive expertise in this area, allowing the lab to support NINDS investigators with flow cytometry-based research assays.

Looking Ahead
The repository aims to continue providing high-quality technical services for the processing, storage, and distribution of clinical specimens, while maintaining meticulous records. Efforts will continue to engage more NINDS investigators and expand service offerings based on demand. One such potential service is DNA extraction from peripheral blood, which has been identified as a highly valuable addition by many investigators. The Core plans to offer this capability in the near future.

Another goal is to develop a basic website to showcase the repository’s mission and procedures, and to make key forms and contact information easily accessible.